Strategies for the Catalytic Synthesis of Nitrogen-Containing Molecules

Project Abstract for NIH R35 (MIRA):
The discovery and development of new methods for the efficient synthesis of N-containing and F-containing
chemical building blocks is an important goal in organic synthesis as a large number of pharmaceuticals and
other bioactive molecules contain these atoms within a diverse set of chemical functional groups. More rapid
and/or selective assembly of known motifs, and moreover the preparation of new chemical landscapes, requires
innovative approaches to drug-like scaffolds, including the discovery of new reagents and new catalysts/catalytic
strategies.
The current goals of this project fall under three main focus areas. 1) We will develop 2-azatrienes, a novel class
of enamine umpolung reagents, for myriad catalytic enantioselective approaches towards chiral amines.
Representative reactions that will be developed include 6,3-, 6,5- and 5,6-hydrofunctionalizations including
reductive couplings with carbonyls and imines, hydroalkynylations, and hydroarylations. Azadienes generated
from 6,5- and 5,6-hydrofunctionalizations of the azatriene reagents may be utilized in myriad downstream
reactions, including other catalytic processes, thereby providing a diastereodivergent avenue towards highly
complex chiral amines through sequential catalysis. 2) We will expand upon our prior work in enantioselective
transformations of 2-azadienes, the first class of enamine umpolung reagents developed in our laboratory.
Examples include reductive couplings with aromatic heterocycles, such as quinoline N-oxides, catalytic
enantioselective fluorofunctionalizations with 4,4-difluoro-2-azadienes, cascade desymmetrization reactions,
and reductive [3+2]-cycloadditions. 3) We will develop catalytic remote C–C and C–B coupling reactions that
result in the loss of a halide from a trifluoromethyl group or H-atom abstraction from a difluoromethyl group to
deliver difluorocarbons in a number of settings. In one case, we will carry out borylation or enantioselective
alkylation of a 3-trifluoromethylpyridine scaffold to yield medicinally important and highly functionalized 3-
(difluoromethyl)pyridines. In another area, we will execute a radical hydrogen atom abstraction of 4-
difluoromethyl-2-azadienes to furnish a difluoro-2-azapentadienyl radical, which then may be engaged in
catalytic cross-couplings to furnish chiral allylic amines bearing a difluoroalkene unit.
Together, these undertakings will enable new chemical space for drug discovery to be obtained readily and with
great diversity from simple reagents. We will access more established N-containing motifs more quickly and with
greater levels of regio/stereocontrol compared to known approaches because of the invention of new reagents
and the novel reactivity that they embody.

Public health relevance
Project Narrative: Small molecule based drugs continue to be a vital avenue for treating human disease. Requiring a chemical landscape that is persistently increasing in complexity, the discovery and development of these pharmaceuticals necessitates continued innovation in the synthetic chemistry involved in their construction if we are to solve outstanding problems in human health. The proposed work will develop new methods for the selective synthesis of a range of nitrogen-containing compounds, especially amines, streamlining and improving routes while also providing access to new chemical landscapes that are comprised of these medicinally proven scaffolds.